PREDICTION OF VIRAL LEAKAGE THROUGH CONDOMS

The proposed research outlines a proprietary, potentially patentable fee- for-service method to predict viral leakage, such as HIV, through condoms - - in manufacturers' production lots during or immediately post production. The study would statistically expand results indicating that among 31 brands, some condoms from brands with lowest ASTM/ISO scores leaded HIV; high scorers did not. 100 condoms from each of four lowest scorers will be challenged with high titre bacteriophage phiX-174, (diam.<HCV/HBV). Leakage will be quantitatively assayed with a detection limit of a single phiX-174 particle leaked through the condom. Test condoms will be pre-stressed on a Coital Simulation Instrument to subject them to reproducible conditions akin to those during sexual intercourse. If leakage is adequately confirmed, future work will similarly more fully assess leakage in high and intermediate scorers, correlating all results with individual ASTM/ISO tests values. Goal: a rapid method predicting production lots' leakage potential, through an ASTM/ISO Index of critical score values. The method has potential as a commercially useful step toward lessening the number virally leaky condoms currently on the market in the AIDS/herpes/chlamydia epidemics. Like FDA water leak monitoring, the method would test production lots, not individual condoms.